Investigation of endomucin as a novel regulator of angiogenesis

Project Summary
We have identified endomucin (EMCN), a component of the endothelial cell (EC) glycocalyx, to be a novel
regulator of VEGFR2 signaling. siRNA-mediated knockdown of EMCN in human retinal capillary EC blocks
VEGF-induced angiogenic functions (proliferation, migration, and tube formation) in vitro and
neovascularization in vivo. Our data indicate that EMCN is necessary for VEGF-stimulated VEGFR2
internalization. We hypothesize that EMCN regulates VEGF-induced VEGFR2 endocytosis, and thus VEGF
signaling in EC. We propose: (i) To use a genetic approach to examine the role of EMCN in developmental
angiogenesis and pathologic neovascularization as well as in adult vascular stability. We have generated mice
with floxed EMCN that will be bred with Rosa-Cre to assess the effect of total EMCN knockout, and with
tamoxifen-inducible VE-cadherin to examine EC-specific knockout. (ii) To elucidate the molecular mechanism
through which EMCN regulates VEGFR2 internalization and signaling, cell biological and biochemical methods
will be employed to determine how EMCN functions in VEGF-VEGFR2 endocytosis, to elucidate the structural
characteristics of EMCN necessary for its role in VEGFR2 endocytosis, and to identify EMCN-VEGFR2 binding
proteins that may be involved in VEGFR2 internalization. (iii) To develop a monoclonal antibody that interferes
with the association between EMCN and VEGFR2, the glycosylated extracellular domain of EMCN will be used
as an antigen. Our preliminary data using truncation mutants of EMCN indicate that the extracellular domain of
EMCN is necessary for its effect on VEGFR2 signaling. Antisera will be screened on the basis of its effects on
VEGF-induced EC migration and VEGFR2 internalization. Antisera, that we have shown to interfere with the
effect of EMCN on VEGF-induced migration and VEGFR2 internalization, will be tested for its the ability to
block pathologic VEGF-induced permeability and angiogenesis in vivo – alone, compared to aflibercept (VEGF
trap), or as a combination therapy with aflibercept. VEGF neutralization is the primary mode of treatment for a
number of ocular pathologies that involve neovascularization and vessel permeability. While remarkably
successful, there is a significant proportion of patients who appear unresponsive to anti-VEGF therapy. In
addition, a number of non-vascular cells in the retina express VEGFR2, and are thus vulnerable to chronic
neutralization of local VEGF, with implications for neurotrophic and survival functions. Results of these studies
will provide new information about the role of EMCN in vascular development, vascular integrity, and
pathologic vessel growth; will reveal novel insights into the regulation of VEGF-stimulated VEGFR2 signaling;
and, will test EMCN as a unique endothelial cell-specific target for blocking abnormal VEGF-induced
angiogenesis and vascular permeability.
!

Public health relevance
Project Narrative Angiogenesis, the growth of new blood vessels, is a destructive component of a number of ocular diseases, including wet age-related macular degeneration. We have shown that endomucin, a glycoprotein located at the surface of endothelial cells, the cells that comprise blood vessels, can regulate angiogenesis. We propose studies to understand the role of endomucin in both normal and abnormal pathologic angiogenesis; to determine at the molecular level how endomucin functions to regulate new blood vessel growth; and, to take advantage of endomucin’s function to develop a novel inhibitor of pathologic neovascularization.